Mayo Clinic StARR Program

PROJECT SUMMARY/ABSTRACT
The overall objective of this program is to provide in-depth research training to qualified individuals and to
prepare them for independent academic careers in the research fields of heart (and vascular), lung,
hematologic (blood), and sleep (HLBS) disorders/diseases. This proposal responds to RFA-OD-11-003 which
identifies the need to enhance the clinician-investigator workforce. We propose that the Stimulating Access to
Research in Residency (StARR) Program at Mayo Clinic will meet this critical need by educating the next
generation of clinician-investigators in a highly supportive environment with strong faculty, leading to the
development of competent investigators in the interdisciplinary field of heart, lung blood and sleep disorders
(HLBS) disorders/diseases research. The StARR award will not only provide incremental value by allowing us
to increase the number of resident investigators currently accepted through the institutionally funded Clinician
Investigator Training Program (CITP), but also will change the landscape of this training by providing, (i)
Focused support to medical residents doing research dedicated to HLBS disorders/diseases; (ii) Infrastructure
and faculty from research-rich departments and divisions (Internal Medicine, Cardiology) to residency training
programs that are clinically strong, but underrepresented in the research arena (Pediatrics, Obstetrics and
Gynecology, and Surgery); (iii) Support and infrastructure-including additional funding opportunities (K38) to
qualified and successful StARR graduates- for a seamless transition from resident investigator to independent
R01-funded research career scientist, which will complement our institutional efforts and resources, (iv) Skill-
building for research preceptors, both for resident investigators and junior StARR faculty, thus ensuring an
ongoing strong mentors for HLBS disorders/ diseases at Mayo Clinic and v) focused effort on recruitment of
women and underrepresented minorities. Our efforts focusing on recruitment while embracing diversity,
education, mentorship, and program evaluation translate into the following specific aims: to attract and retain
resident-investigators from diverse cultural and educational backgrounds for academic careers in HLBS
disorders/diseases research (Aim 1); to train and prepare resident-investigators for independent research
careers (Aim 2); and to evaluate the effectiveness and success of the Mayo Clinic StARR Program (Aim 3).
In summary, the proposed StARR grant addresses a critical void, and will train a new generation of clinician
scientists with the necessary skills to address the complex field of HLBS disorders/diseases that crosses
research fields of expertise and medical specialties. The training will take place in a highly supportive
environment with experienced mentors, leading to the development of well-prepared investigators in the
interdisciplinary field of HLBS disorders/diseases research.

Public health relevance
PROJECT NARRATIVE In the research fields of heart (and vascular), lung, hematologic (blood), and sleep (HLBS) disorders/diseases, there is an increasing demand for investigators with training in multiple disciplines. However, fewer and fewer physicians are pursuing research careers. We propose that the Stimulating Access to Research in Residency (StARR) Program at Mayo Clinic will enhance the clinician-investigators workforce by educating the next generation of clinician investigators in a highly supportive environment with strong faculty, leading to the development of competent investigators in the interdisciplinary field of HLBS disorders/diseases research.